Regulation of beige adipocyte maintenance and its impact on metabolic outcomes

Title: Regulation of beige adipocyte maintenance and its impact on metabolic outcomes
Project Summary/Abstract
A potential therapeutic target to curb the global obesity and diabetes epidemic is thermogenic beige fat within
white adipose tissue (WAT). Unlike white adipocyte which stores fat, beige adipocytes are stimulated
thermogenic fat cells in WAT that robustly consume lipid and glucose. However, Beige adipocytes quickly
disappear upon the removal of stimuli, a process further accelerated by age and obesity. This creates a key
challenge to explore beige adipocytes as a sustainable therapy for chronic metabolic diseases. A long-term goal
of my laboratory is to understand the development and maintenance of beige adipocytes, and the metabolic
outcomes. In our preliminary studies using unique mouse models, we demonstrate that beige adipocytes can be
induced and maintained by pharmacological and genetical measures. Further, our preliminary results suggest
that these induced beige adipocytes are maintained in the older mice, even without continuous stimulation.
These exciting findings, although preliminary in nature, suggest novel measures to use beige adipocyte as
potential therapeutics to treat obesity, diabetes, and other metabolic diseases. In this application, we will
investigate whether the sustained beige adipocytes can improve the metabolic fitness under both health and
disease conditions, thereby achieving anti-obesity and anti-diabetes effects. Furthermore, we will elucidate the
critical molecular mechanisms by which beige adipocyte identity is preserved. In addition, we will employ cell-
type selective transcriptomic approach to comprehensively characterize the molecular components involved in
beige adipocyte maintenance.

Public health relevance
Project Narrative Recruitable thermogenic beige adipocytes have been thought to be short-lived, rapidly converting to “white-like” adipocytes after discontinuing the stimuli. This creates a key challenge to explore beige adipocytes as a sustainable therapy for chronic metabolic diseases. We have recently discovered that beige adipocytes have the ability to stay long-lived and subsequently improve energy expenditure and metabolic fitness. This proposal is designed to leverage our expertise in adipocyte biology and mouse genetics and study the mechanism on how beige adipocytes lose their cellular identity under both physiological and pathological conditions, and how this progress can be maintained to combat obesity and insulin resistance.